Studies of Pediatrics patients with genetic and metabolic disorders

Evaluations of patients with a broad spectrum of metabolic and genetic conditions are performed; we have evaluated a total of 386 under this protocol. In addition, genetic counseling services are offered to patients and their families to assess risk, and give information on preventive measures, and testing options. Disorders that are studied include chromosomal and Mendelian disorders of childhood and/or adult onset, congenital anomalies and/or birth defects, dysmorphic syndromes, familial cancer syndromes, multifactorial disorders, and metabolic abnormalities. If not eligible for an NICHD research protocol (specific for a disease or a treatment), patients with genetic/metabolic-related conditions may be evaluated under the auspices of this protocol to advance the clinical skills of physicians participating in NICHD clinical research and training programs, and to provide stimuli for new clinical research initiatives. Standard, medically indicated laboratory or radiological studies may be performed to confirm a diagnosis or to aid in the management of the patient. In some cases, the patients receive medical or surgical treatment for their disorder, according to current clinical practice. Patients and/or family members with genetic disorders may offer their DNA for storage and/or testing. The overall purpose of this protocol is to support our Institute's training and research missions by expanding the spectrum of diseases that can be seen in our clinics and wards.